Novel strategies to improve mesothelioma therapy

PROJECT SUMMARY
Exposure to asbestos fibers is the major risk factor for the development of malignant mesothelioma (MM). We
demonstrated that asbestos fibers induce HMGB1 translocation from the nucleus to the cytoplasm, inducing
autophagy, a protective mechanism for mesothelial cells survival after asbestos exposure and contributing to
malignant transformation. Our findings that autophagy is constitutionally activated in MM cells explains MM
chemoresistance. Antidepressant drugs (ADs) were shown to block autophagy and our preliminary data
suggested that ADs, well-tolerated drugs, inhibited autophagy in MM cells. Moreover, we discovered that a
mitochondrial protein called Mcl-1 blocks chemotherapy-induced apoptosis. Inhibition Mcl-1 increased the
effects of chemotherapy five-fold, suggesting that the combination of ADs with Mcl-1 inhibitor may be
particularly effective in treating MM. Here we propose to test our hypothesis that autophagy MM growth and
chemo-resistance, and that ADs, by inhibiting autophagy, increase the sensitivity of MM to chemo-induced
apoptosis, which can be further enhanced by Mcl-1 inhibition. To address this hypothesis, we will examine the
following aims:
AIM 1: To investigate the mechanisms responsible for the resistance of MM cells to chemotherapy.
AIM 2: To investigate whether ADs and the Mcl-1 inhibitor increase the efficacy of chemotherapy in MM in
mouse models.
AIM 3: To investigate, using biopsies from MM patients, the effects of ADs and the Mcl-1 inhibitor, AZD-5991,
on tumor cells and the tumor microenvironment, and assess survival.
Our novel and unique reagents and resources will help us understand the specific functions of HMGB1 and the
related mechanisms that induce autophagy and facilitate MM progression, which may therefore be the most
clinically relevant targets for intervention. Using ADs and the Mcl-1 inhibitor to help sensitize MM to
chemotherapy will be extremely translational. This study is of great impact to accelerate the development of
more effective therapeutic strategies to improve the prognosis of this devastating malignancy.

Public health relevance
PROJECT NARRATIVE We discovered that HMGB1 induces autophagy –a pro-survival mechanism in malignant mesothelioma (MM) that leads to chemo-resistant, and we found that antidepressant drugs (ADs) inhibit autophagy and sensitize MM cells to chemodrugs-induced apoptosis. Moreover, mitochondria protein, Mcl-1, blocks MM cell death when treated with chemotherapy. Here, we propose to study whether ADs may improve chemotherapy and whether that effect is further enhanced in combination with Mcl-1 inhibition.